Administrative Core

ADMINISTRATIVE CORE
Abstract
The Administrative Core provides overall leadership and management support to the Center, supports the work
of all Cores, facilitates communication across cores and the broader CIRA community, conducts strategic
planning to identify new scientific direction and stimulate interdisciplinary research collaborations, and monitors
and evaluates the impact of the Center. The Core provides the fundamental infrastructure to facilitate the
achievement of CIRA goals and coordinates and integrates the activities of all CIRA cores. In the next 5 years,
CIRA will focus on stimulating and supporting innovative interdisciplinary research that combines behavioral,
social, structural, and biomedical approaches to improve HIV equity of status neutral HIV care (i.e., HIV
prevention and treatment services across the care continuum, regardless of one’s HIV status). We will
leverage the extensive multidisciplinary expertise of our scientists and community partners to have substantial
impact on the global epidemic through a focus on HIV equity through the support of key research skills shown
to improve equity: implementation science, community-engaged research, HIV service integration, and digital
health. The Admin Core has guided the development of greatly expanded opportunities for scientific exchange,
fostering relationships across Cores, supporting the development of the New England HIV Implementation
Science Network (NEHIS Network), revitalizing CIRA’s international research program to expand CIRA’s
engagement in areas with high HIV burden and disparities, and adding leadership training and development
focused particularly on CIRA’s Associate Directors, in order to foster the next generation of leaders in HIV
equity research, and create a robust succession plan so the Center can continue to lead in addressing status
neutral HIV care and its comorbidities, most notably mental health and substance use. The Admin Core will
play a leading role in furthering CIRA’s mission at the regional, national, and global levels. CIRA will continue a
strong presence and connection with local work on status neutral HIV care, maintaining ties with departments
of health and HIV service organizations in Connecticut as well as throughout New England through the NEHIS
Network. The Administrative Core will also continue to nurture and integrate affiliates based outside of Yale,
many of whom are graduates of our successful training programs and wish to continue to benefit from the rich
resources and supportive culture at CIRA. This includes coordinating CIRA’s research agenda with other
NIMH-funded P30 AIDS Research Centers (ARC) through scheduled ARC teleconferences that promote
synergy across ARCs. The Administrative Core will oversee all functions of the Center and help to integrate
and align services and activities across the Cores to maximize the scientific and public health impact of CIRA
on the HIV epidemic in New England, nationally, and globally.